Center for Healthy Aging Behaviors & Longitudinal InvestigationS (CHABLIS)

PROJECT SUMMARY/ABSTRACT
The purpose of the proposed University of Chicago (UChicago) Center for Healthy Aging Behaviors and
Longitudinal InvestigationS (CHABLIS) is to promote a sustained research and infrastructure development
program that leverages longitudinal data, from both observational and interventional studies, to examine how
demographic and economic factors facilitate or suppress individual healthy aging behaviors (HABs) and, in turn
influence outcomes among older adults over the life course. Spanning five divisions and schools and
partnering with the National Opinion Research Center (NORC), CHABLIS will bring many areas of expertise
and multiple methodologies to bear on the demography and economics of aging. The central thesis of this
proposal is that CHABLIS connects schools, disciplines (e.g., economics, sociology, medicine), and people.
We aim to: 1) enhance and lead innovation in the demography and economics of aging; and 2) cultivate the
next generation of leaders in social science approaches to aging research with attention to demographic
methods and approaches. The Program Development Core focuses on providing research and career
development support to early-career faculty and supporting pilot projects that span the demography and
economics of aging in both medical and social science realms. Our External Innovative Network Core draws on
the infrastructure of the National Social Life, Health and Aging Project (NSHAP), and our local Comprehensive
Care Physician (CCP) Program, to create opportunities for exchange and research synergies between these
two different forms of data collection and research. The External Research Resources Support and
Dissemination Core is a joint effort with the Duke Center for Population Health and Aging (CPHA). Its goal is to
identify, design, conduct and assess innovations in data collection and measurement for use in current and
future data-focused studies of aging, and share those findings immediately. The emphasis in that Core, and
throughout our proposal, is that longitudinal data collection efforts are central to research on aging, whether
they be local (e.g., CCP) or national (e.g., NSHAP); data collection processes must be continually advanced to
ensure that these data are relevant and used. Our Administrative and Research Support Core lays out our
move, both physically and administratively, to the Center for Health and the Social Sciences (CHeSS). This
Core will manage all aspects of the enterprise and will conduct expanded evaluation activities. CHABLIS
enjoys the strengths of a productive and influential set of senior scholars who will effectively mentor its early-
career faculty members.

Public health relevance
PROJECT NARRATIVE The University of Chicago (UChicago) Center for Healthy Aging Behaviors and Longitudinal InvestigationS (CHABLIS) will promote research in the demography and economics of aging and assist junior scholars as they engage in this research domain. We draw on projects such as NSHAP and CCP to develop opportunities for scholars, both junior and senior, to collaborate on science and survey methods in a longitudinal context.